Institutional Career Development Core

I. Institutional Career Development Core: Project Summary
The KL2 training program within OCTRI is built on a strong foundation of excellent scholar outcomes, with a
strong rate of progression to independent funding, a diverse pool of faculty scholars, and supportive
mentorship. Scholars and the mentor pool are recruited from OHSU and our academic partners, University of
Oregon, Oregon State University, and Portland State University.
The goal of the OCTRI KL2 program is to train a corps of clinical and translational scientists in the skills and
competencies of clinical and translational research who can employ cutting edge technologies to translate
discoveries made in the laboratory to the patient and the community. Through this program, we will select
outstanding early faculty who are committed to developing a research career; each of the scholars will
participate in a mentored research experience with a minimum protected time of 0.75 FTE. Scholars will
develop a career development plan with the aid of a mentor team – which will include a designated primary
mentor – to assist with career development, networking, manuscript writing, and grant development.
Scholars form an independent development plan with their mentor and program leadership to enhance their
research competency. Training is individualized and scholars participate in activities to enhance their research
and career development needs: development of research competencies in clinical and translational research,
professional activities, and experiential learning. Scholars enroll in the curriculum of the Master of Clinical
Research program; all scholars must participate in training in qualitative methods, scientific communication,
and research leadership. Professional development includes opportunities through the OCTRI Scholar
program for peer networking, Design Studio, and access to research consultation. Community engagement will
be emphasized in research development, with all scholars gaining experience with stakeholders. Scholars will
also gain experience with grant writing and grant review.
The goal of this program is to produce an independent, transdisciplinary clinical and translational researcher.
The expectation is that scholars will move to an independent K award at the end of the KL2 funding period.